Penn State Family Issues Symposium

ABSTRACT
This application requests an additional five years of support for the Penn State Family Issues Symposium, an annual
interdisciplinary conference designed to focus attention on understudied issues that are important for understanding family
structure and function and their impacts on the behavior, health and development of family members, particularly children
and youth. Our application is responsive to the call in NICHD’s Scientific Vision: The Next Decade, which identified
population dynamics as a priority and argued that advancing knowledge in this area “starts with understanding the rapid
and profound changes shaping families in the United States and around the world. This includes understanding how
biological, social, and other environmental factors, in concert with population dynamics, influence the health and well-
being of mothers, fathers, children, families, communities, and societies.” This proposal builds on a 26-year tradition of
annual symposia that have been co-organized by faculty members from the departments of Sociology and Human
Development and Family Studies with financial support from Penn State’s Population Research Institute, Social Science
Research Institute, numerous other Penn State departments and centers as relevant for particular symposium topics, and
the NICHD.
Aims of the symposium series are: (1) to promote dialogue that stimulates and advances novel interdisciplinary and
translational research on family issues; (2) to promote understanding of and scholarly excellence in basic and translational
research on families; and (3) to identify and address significant, emerging issues in the field of family studies that have
not yet received substantial research attention or been the focus of other conferences and meetings and wherein
knowledge can be advanced by interdisciplinary and translational research.
To address these aims, the symposium series is designed to foster discussion among scholars whose work ranges from
more basic to more applied and who might not otherwise find opportunities for exchange, to produce a book series for
broad dissemination of the symposium’s knowledge contributions, and to engage students and junior scholars−the next
generation of family researchers.

Public health relevance
PROJECT NARRATIVE Families around the world are experiencing dramatic changes that have had and will continue to have extraordinary consequences for their members and for society at large. Understanding these changes and providing evidence to inform family-focused policies and programs that can promote the health and development, particularly of children and youth, requires the best minds in the country. The promise of novel discovery and its translation into evidence-based practices and policies that address the complex system of influences that impact families will be best advanced via the kind of interdisciplinary forum for discussion and intellectual exchange that the Family Symposium series aims to provide.